INHALED SULFUR DIOXIDE AND OZONE ON IMMUNE REGULATION IN ASTHMA

The purpose of this study is to determine the effects of inhaled sulfur dioxide and ozone by subjects with mild asthma on cytokine (IL-10) and TH2 lymphocyte levels in bronchoalveolar lavage fluid.